Characteristics and protective efficacy of human antibodies against M. tuberculosis

Abstract
Active tuberculosis (TB), a transmissible uncontrolled respiratory infection caused by Mycobacterium
tuberculosis (Mtb), is a global public health problem and one of the top 10 causes of death worldwide. More
effective vaccines for the protection against TB are urgently needed. The currently available Bacillus Calmette-
Guerin (BCG) vaccine has been in use for almost a century but provides insufficient protection against TB. A
major obstacle in the TB vaccine field is the limited understanding of the full breadth of the immune components
involved in the protection against TB. Currently, TB vaccine development is focused on eliciting or boosting cell-
mediated immunity, but increasing evidence suggests that antibodies also have a role in the protection against
TB. To gain a better understanding of specific protective antibody responses that could be induced in humans
by vaccination, detailed characterization and functional studies of human polyclonal and monoclonal Abs (mAbs)
to potentially protective epitopes are required. Antibodies to capsular and other surface polysaccharides are
protective against a several microbial pathogens, including those with intracellular location such as Mtb. Human
antibody levels to Mtb capsular polysaccharides are not only greatly variable, they are also tremendously
heterogeneous in their binding specificity to oligosaccharide motifs within the polysaccharide. Our published and
preliminary data suggest that protection is due to IgG reactivity to specific oligosaccharide motifs. Based on
these novel data, our overarching hypotheses are: 1) Human antibodies to specific capsular polysaccharides
are protective against Mtb; and 2) protection by these antibodies arises from reactivity to specific oligosaccharide
motifs within the polysaccharide. Our specific aims are: 1. To generate and characterize human polyclonal and
mAbs to Mtb surface glycans; 2. To determine the effects of Mtb surface-specific human Abs on macrophage
functions; and 3. To establish the protective efficacy of Mtb surface-specific human Abs in vivo.
Our overarching goal is to determine the oligosaccharide epitopes of Mtb surface carbohydrates that are most
relevant for protection Although some of our most successful vaccines are based on inducing antibodies to
capsular polysaccharides, the field has started to move to oligosaccharide-conjugate vaccines, which, in addition
to targeting the most relevant epitopes, have the advantage of greater product consistency compared to the
heterogeneous preparations of purified polysaccharides of most marketed glycoconjugate vaccines. The
knowledge gained could inform new strategies for developing both vaccines and Ab-based immunotherapies
against TB.

Public health relevance
Narrative Tuberculosis (TB) is one of the deadliest infectious diseases and remains major a global public health problem. Development of an effective vaccine and new immunotherapies against TB is critically dependent on a better understanding of all the immune component involved in preventing and controlling Mycobacterium tuberculosis infection. This application seeks to generate and evaluate polyclonal and monoclonal human antibodies to study their functions and demonstrate their protective efficacy in vitro and in vivo. The overall goal of the proposed studies is to inform new development strategies for TB vaccines and antibody-based therapy.